Environmental Sensor for Detection of PFAS

Summary Abstract
Even though our environment is overrun with thousands of toxic perfluoroalkyl substances
(PFAS) that can cause severe human health damage, monitoring agencies struggle to reduce
them given detection tool limitations. Human-made PFAS are “forever” chemicals that do not
naturally degrade. They migrate to the air, food, soil, and water, accumulate in the body, and
can result in conditions from liver damage to decreased fertility and cancer. Soluble and aerosol
forms of PFAS are discharged through waterways and stacks are in our agricultural products,
and detectable in the blood of 98% Americans. The EPA has testified to the Senate Committee
on Environment and Public Works of a list of 180 Superfund Sites in 47 states, including
Department of Defense (DOD) bases, landfills, farms, transportation hubs and national
laboratories. The DOD estimates that its PFAS cleanup costs would total more than $3.2 billion.
Right now, researchers, epidemiologists, governments, and environmental monitoring
companies seek technology for population studies to monitor personal exposure. Health
professionals need reliable and accurate information to develop effective policies and
interventions to protect public health. Further, the call for sensors for detection and monitoring of
contaminants in environmental samples is increasing. In short, there is an urgent need for
inexpensive and versatile sensors for sensitive and selective point-of-use detection of emerging
environmental contaminants. Available technologies have limitations which prevent their
successful commercialization. Field detection of personal exposure to PFASs in water below 4
ppt, set by the EPA as regulatory limits in drinking water, is currently unachievable for
researchers. Conventional detection approaches involve sending field samples to accredited off-
site professional laboratories for costly and time-consuming analytical protocols that deliver
results in weeks. Pearlhill Technologies proposes developing the environmental optically gated
transistor (ENVIR-OGT) sensor to measure chemically-induced electrical response in air and
water. SPECIFIC AIMS — (1) Develop the ENVIR-OGT detection matrix (EODM) analytical
method validation guideline, and (2) Determine EODM analytical method validation
characteristics. Phase I will demonstrate technical merit and feasibility as a new population
study tool to measure personal exposure. It will advance epidemiological research
understanding about PFAS exposure and human health, as well as likely policy. In Phase II, we
hope to test unique ENVIR-OGT sensor capabilities and further validate Phase I by increasing
the PFAS it detects.

Public health relevance
The proposed project is relevant to public health because researchers, epidemiologists, governments, and environmental monitoring companies lack detection tools to effectively reduce widespread, life-threatening toxins that threaten public health, and occupational health. These groups complete population studies to monitor personal exposure and advance public health policy, but lack inexpensive and versatile sensors for sensitive and selective point-of-use detection. Pearlhill Technologies proposes developing the environmental optically gated transistor detection matrix (EODM) for the ENVIR-OGT sensor as it uses chemically-induced electrical response for superior detection at speeds not currently possible, will be usable on site and in real time in both air and water, and at costs and sizes that will improve access.